Small molecules targeting RuvBL complex for triple negative breast cancer

Abstract
The goal of this project is to develop small molecule modulators of RuvBL1/L2 complex as potential therapies
for triple negative breast cancer (TNBC) by targeting DNA double-strand breaks (DSB) repair pathways. TNBC
is a subgroup of breast cancer and is molecularly characterized by the lack of expression of estrogen receptor
(ER), progesterone receptor (PR) or HER2 (human epidermal growth factor receptor 2) amplification. DNA
replication stress and reactive oxygen species are prevalent in TNBC cells due to activation of various
oncogenes. Thus, TNBC cells constantly generate DSBs. In order for the TNBC cells to survive, these lethal
DSBs must be repaired. Accordingly, over the course of development of cancer, TNBC cells have co-evolved
efficient DSB repair mechanisms that protect them from the endogenous lethal DSBs. Therefore, targeting
DNA repair pathways has been proposed as a potentially powerful strategy to develop novel therapeutics for
TNBC. By exploiting this unique feature of endogenous DSBs prevalent only in TNBC cells, such therapeutics
can offer selective toxicity to TNBC cells without harming normal cells. We recently identified a novel small
molecule lead compound to target RuvBL1/L2 to inhibit DSB repair in TNBC cells. In this application, we
propose to further develop this small molecule lead compound for the treatment of TNBC with 3 specific aims.
In aim 1, we will study the mechanism of action of this novel lead compound. In aim 2, we will optimize this
lead compound using different medicinal chemistry strategies. In aim 3, we will investigate the optimized
compounds' anti-TNBC efficacy in different preclinical models alone and in combination with PARP inhibitors.

Public health relevance
Project Narrative The proposed research is to develop novel inhibitors for RuvBL1-L2. These inhibitors can be potential therapeutic agents for triple negative breast cancer.